Administrative Core (A)

CORE A – Administrative Core
This Conte Center – Understanding latent cause inference in health and illness – will bring together 10 highly
accomplished investigators from two neighboring institutions, Princeton University and Rutgers University,
who will employ a multidisciplinary computational-translational approach to investigate latent cause
inference. In keeping with the team's strong collaborative tradition and years of communication around the
ideas at the heart of this proposal, each Project and Core will be co-led by multiple investigators, each of which
is involved in more than one component of the Center.
Within this highly integrated setting, the Administrative Core A will provide administrative oversight and
support to all Projects and Research Cores to coordinate their activities, facilitate data-sharing, and foster close
collaborative links and synergy that will be critical to the success of the Center.
Core A has the following three aims:
Aim 1 - Facilitate scientific oversight through effective communication and coordination. Core A will
provide structure and robust mechanisms for communication and the exchange of data, ideas and discoveries
through regular videoconferences and face-to-face meetings. The Core will also provide support for all
administrative responsibilities of the Center, including monthly budget reports, annual allocation and re-
allocation of budgets, progress reports, and coordinate meetings among all investigators.
Aim 2 - Administer and oversee data-sharing within the Center and with NIMH. Core A will create a secure,
shared-resource repository where all data and code can be shared freely across Projects and Cores, oversee
submission of resources into this repository, and establish a system for obtaining data for analysis by other
researchers. The Core will also oversee and facilitate data-sharing of human subjects data on the NIMH Data
Archive twice yearly, as well as sharing of data and code from published papers using the Open Science
Framework. We are committed to open science and view data and resource sharing as integral to our goals.
Aim 3 - Coordinate training and outreach. Core A will develop and implement training programs for research
assistants, students, and postdoctoral fellows; develop and administer a summer undergraduate research
program in coordination with similar existing programs at Princeton and Rutgers; and coordinate public
outreach of Center discoveries including the development and maintenance of a website to provide a hub for
sharing findings and resources with the broader scientific community and the general public.